Systemic and local immunomodulation of fracture healing in polytrauma

Project Summary
The economic cost of traumatic injuries accounted for approximately 20% of the US economy in 2019, and were
a top ten cause of death in the United States.1 More than one half of this cost ($2.4 trillion) was among working-
aged adults (aged 25–64 years).1 Musculoskeletal injuries, including fractures, are by far the most commonly
involved body system injured in multisystem trauma.2 This interaction of systemic trauma and fracture healing
has profound effects on patient recovery, quality of life, and societal resource utilization.
The field of bone regeneration has been primarily focused on healing fractures and treating bone loss in the
context of isolated musculoskeletal injuries. Most closed, isolated fractures heal well in contrast to fractures in
polytrauma patients which exhibit impaired healing in greater than 30% of cases.3,4 Clinical evidence suggests
there may be distinct physiologic, cellular, and molecular mechanisms contributing to fracture repair in
polytrauma. The underlying mechanisms contributing to fracture repair in polytrauma environments are poorly
studied.
This proposal is structured to interrogate the role of polytrauma on fracture repair. Leveraging my combined
orthopaedic surgeon clinical experience and training in mechanistic research, I will investigate the role of
inflammation and immunomodulation in a polytrauma model of fracture healing, focusing specifically on the
response of mesenchymal stromal cells (MSCs). (1) I will first characterize the upregulation of inflammatory
cytokines and innate immune cells both systemically and locally at the fracture site in the presence and absence
of polytrauma. (2) I will then characterize the anti-inflammatory and therapeutic effects of MSCs on fracture
healing when delivered systemically versus locally to the fracture site in a murine polytrauma model.
My career goal is to conduct clinically relevant mechanistic research as an orthopaedic traumatologist. This K08
proposal will allow me to focus my efforts on acquiring the skills necessary to become a successful, independent
clinician-scientist. My prior experience in the lab has afforded me the deep appreciation for the rigors of scientific
inquiry, experimental design, and data analytics. I am already quite familiar with many techniques and through
this career development grant, I will expand my mechanistic skillset. This award will provide a solid foundation
for ongoing rigorous study design, execution, troubleshooting, and data management that will launch an
independently funded, clinically relevant, research career. My advisory committee is comprised of highly
accomplished and diverse group of mentors who will help catalyze my continued growth into a competitive
researcher in the field of bone injury and healing. I am fortunate to be part of a world-class trauma unit with
clinical partners who will support my clinical load and protect my time for the intensive demands of executing
rigorous science. By harnessing my unique position, I will focus my research endeavors to combat the ubiquitous
societal scourge of musculoskeletal trauma and advance fracture care with a goal of enabling patients to recover
more effectively.

Public health relevance
Narrative Fractures in polytrauma patients often do not heal, leading to patient morbidity, poor clinical outcomes, increased healthcare costs, and economic loss. There are significant gaps in our understanding of the unique challenges of fracture healing in a patient sustaining polytraumatic injury. This study will investigate how inflammation, immune system function, and stem cell activity affect fracture healing in polytrauma.